Treatment of Veterans with Heart Failure with Reduced Ejection Fraction with Probenecid

Heart failure with reduced ejection fraction (HFrEF) is a common cause for admission
within the Veterans Affairs (VA) Health Care System. It is associated with severe impairment of
physical and mental health status, and carries a high 5-yr mortality rate of ~75%. Even though
significant progress has been made in understanding its pathophysiology, currently, its
management and treatment is based on therapeutic targeting of a limited number of receptors
and pathways.
Our team and others have made great progress in the last few years by understanding
and harnessing the Transient Potential Receptor superfamily as regulators of cardiovascular
function. Specifically, our laboratory has explored the role the vanilloid 2 (TRPV2) subtype plays
in regulating calcium handling and contractility. This work has led us to understand that TRPV2
modulates contractility via increasing calcium cycling in myocytes on a beat-to-beat basis.
We have used probenecid, a generic, globally available drug with an extremely safe
profile that has been used for decades as a treatment for gout, as a TRPV2 agonist. Our work
with this drug has demonstrated it to be a potent inotrope without apoptotic, chronotropic or
arrhythmogenic effects in cardiomyocytes in vitro as well as in vivo murine and porcine models.
These findings have been taken to the bedside with a recently published small phase 2 study of
20 adult patients with HFrEF (the ReProsper HF pilot study) where we demonstrated a mean
improvement in left ventricular systolic and diastolic function with no adverse effects after only 1
week of treatment. The use of probenecid in HFrEF was also indirectly supported by a recent
retrospective study of approximately 40,000 patients in the Medicare database that found
treatment with probenecid (not specifically for heart disease) was associated with a 9% decreased
risk of HF hospitalization. These studies strongly argue for the safety and potential efficacy of
probenecid to improve systolic function and the need for a larger study, and of longer duration
that also evaluates functional and health status outcomes in addition to systolic function.
The overall objective of this study is the treatment of outpatient veterans with NYHA II-III
heart failure with reduced ejection fraction (HFrEF) with probenecid to improve systolic and health
function. Specifically, we are proposing a three-site double-blinded, randomized, placebo-
controlled, three-site trial that will assess whether oral probenecid administered at 1 gr. orally
twice per day for 180 days in patients with NYHA II-III HFrEF improves systolic function as
measured via ejection fraction with echocardiography (aim 1); improves functional status as
measured by exercise stress testing (aim 2); and improves self-report heart failure specific health
status as measured by Kansas City Cardiomyopathy Questionnaire (KCCQ) and overall health
status measured by EQ5D (aim 3).
This trial is highly relevant to the VA population as HFrEF has been the number one reason
for admission among patients in the VA Health Care System and it is highly innovative as it will
seek to repurpose a previously established safe drug for a novel indication based on extensive
animal, preclinical and population based studies. If successful, this study will not only provide a
novel therapy it will also provide the necessary event rates for a future larger study to establish
its role in improving hospitalization and mortality.

Public health relevance
Heart failure with reduced ejection fraction (HFrEF) is a common cause for admission and mortality within the Veterans Affairs (VA) Health Care System. Currently its treatment is based on therapeutic targeting of a limited number of receptors and pathways. Our team has shown that the Vanilloid 2 subtype of the Transient Potential Receptor superfamily (TRPV2) modulates cardiac function and we have used probenecid, a generic, globally available drug with an extremely safe profile as a TRPV2 agonist. Our work has demonstrated probenecid to be a potent inotrope without significant adverse effects in animal models and in patients with HFrEF. The objective of this study is the treatment of outpatient veterans with HFrEF with probenecid to improve systolic and health function. If successful, this study will provide a novel therapeutic option for patients with HFrEF and will provide event rates for a larger study with hard endpoints.